Identification of Sex Specific Regulatory Drug Targets for Chronic Neuropathic Pain

Project Summary Chronic pain disproportionately affects women, but the majority of preclinical research uses male subjects. Several recent studies show that microglia have a key role in the development of neuropathic pain in male mice, but have no contribution in female mice, where as our preliminary data demonstrate that the pharmacological inhibition of calcitonin gene-related peptide (CGRP) receptors reverses hyperalgesic priming in female mice, but has no effect in male mice. We hypothesize that the mechanisms driving pain plasticity in females rely on a neuronal regulatory program, but a neuro-immune regulatory program drives chronic pain in males. Our research plan proposes to first analyze single-cell RNA sequencing data from male and female mice to independently confirm our preliminary findings and elucidate new targets and/or mechanisms for the development of novel neurotherapeutics for the treatment of chronic pain. We will next confirm that the gene families identified to mediate chronic pain in mice are conserved in human chronic pain patients. We will do this by performing weighted gene co-expression network analysis on existing mouse and human RNA-seq datasets and then perform differential expression analysis on the genes identified in both mice and humans. The work described in this proposal will unveil sex-specific pain plasticity mechanisms that can have an immediate translation impact given the number of anti-CGRPP therapeutics available for use in patient populations. New drug targets will also be identified for pre-clinical validation and development.

Public health relevance
Project Narrative Recent work by our lab and other groups has demonstrated sexually dimorphic mechanisms underlying the development of chronic neuropathic pain. The goal of this project is to determine the underlying mechanistic differences that differentially contribute to chronic pain in male and female mice. To complete this goal we will use computational analysis, including WGCNA, which will create an excellent training vehicle to determine sex- specific pathways contributing to neuropathic chronic pain and find drug targets for novel therapeutics.